LYMPHOKINE PROFILES IN ASTHMA AND ALLERGIC DISEASES

Asthma is an inflammatory disease of the airways. After allergen exposure, IgE bearing cells, such as mast cells and basophils, are first activated. Later, T lymphocytes enter the airways, are activated by allergen and play a key role in regulating this inflammatory response through the elaboration of cytokines such as IL-4, IL-5 and IFN-gamma. This project seeks to examine the cytokine profiles of mast cell, basophil and T cell subpopulations that may be involved in the generation of inflammation in asthmatic airways. One goal is to identify mast cell and basophil products that may contribute to bronchial inflammation. A second goal is to define the cytokine profile of peripheral blood and bronchoalveolar lavage (BAL) T cells from asthmatics and normal volunteers, to determine if indeed there is preferential trafficking of specific cytokine producing T cell subsets. Finally, we wish to characterize human NK1 T cells, which in mouse models of allergy play a key role in initiating Th2 polarized T cell responses. To date, we have found that human mast cells, including those in the lungs, produce and secrete IL-16, a chemotactic factor for CD4 T cells. IL-16 accounts for a majority of the CD4 T cell chemotactic activity secreted by mast cells. This trafficking of T cells to the allergen exposed lung has been examined by bronchoalveolar lavage, demonstrating a predominant Th1 profile. We have also identified a human analog of the previously described murine NK1 T cell, characterizing their unique TCR usage of V-alpha-24, V-beta-11. IL-4 was expressed in NK1 T cells at a 6 fold greater level relative to mainstream T cells and was uniquely found in cells of a Th0 dual expressing phenotype. Using similar techniques, we have shown that basophils obtained from allergic asthmatics are the predominant source of IL-4 in peripheral blood mononuclear cells.